Statistical Methods for Kidney Markers as Shared Determinants of Dementia and Physical Disability in Older Adults

Dementia affects over 44 million adults worldwide, and Alzheimer’s disease (AD) and related dementias
(ADRD) account for 60-80% of all cases among older adults. Physical disability is often the final consequence
of dementia before death. One-third of dementia cases may be attributable to modifiable factors, and due to
unclear benefit of approved AD treatment, there is a need to identify intervention targets to prevent dementia
and physical disability. Since both conditions may be preceded by declining cognitive and physical perform-
ance by over a decade, shared biological determinants of dual cognitive-physical decline that impact neuro-
logical, musculoskeletal, and other organ systems may inform therapeutic targets to prevent dementia and
physical disability. Separate research on these endpoints indicates that declining kidney function, which is a
model of premature aging, relates to both cognitive and physical decline. Trials of treatments to reverse kidney
disease are underway, but prevention may be more effective. Thus, identifying early markers of kidney decline
that are related to dual cognitive-physical decline and joint dementia-disability onset in initially health older
adults is a key step toward this goal. Beyond known kidney effects on bone, a kidney-brain axis and kidney-
muscle axis posit multiple mechanisms by which declining kidney health may lead to dementia and physical
disability such as kidney aging, impaired mineral homeostasis, and accumulation of uremic markers. However,
epidemiologic studies have not rigorously investigated whether kidney markers of these biological mechanisms
affect relations and dynamics between cognitive and physical endpoints. Plus, studies of longitudinal cognitive
and physical endpoints are vulnerable to survival bias and unmeasured confounding. Limitations of current
statistical methods are a key barrier to accurately quantifying the strength of relations between cognitive and
physical endpoints and to identifying markers of shared biological mechanisms to explain these relations.
Thus, new statistical methods are needed to overcome these barriers. Specific aims of this proposal are to: 1)
quantify relations between cognitive and physical endpoints over time; 2) test relations of kidney markers with
cognitive-physical endpoints; and 3) develop/validate a biomarker risk score to jointly and dynamically predict
dementia and disability. To this end, we propose to extend novel structural models for multivariate longitudinal
and time-to-event outcomes and apply them to harmonized data from 8 cohort studies of >22,000 community-
dwelling adults aged at least 65 years. We hypothesize that after addressing survival bias, cognitive and
physical endpoints will have stronger relations that are explained and predicted, in part, by markers of kidney
aging, impaired mineral homeostasis and by accumulation of uremic markers. New statistical methods
developed as essential tools to jointly study cognitive and physical endpoints will be made available to the
scientific community. The ultimate public health impact of this project is the potential for novel candidate
biomarkers to inform development of new strategies to prevent ADRD and physical disability in older adults.

Public health relevance
The over 44 million persons worldwide living with dementia are primarily older adults with Alzheimer’s Disease (AD) or related dementias (ADRD). The consequences of physical disability and death from AD combined with unclear clinical benefit of AD treatment motivate the search for targets of preventive intervention. We hypothesize that declining kidney health, which is a model of premature aging that relates to cognitive and physical decline long before onset of dementia and physical disability, is the source of modifiable biological mechanisms; thus, we propose to leverage data from over 22,000 older adults to identify kidney-related biomarkers that can inform prevention and prediction of age-related ADRD and physical disability.